DERIVATIZATION OF POLYURETHANES TO PROMOTE BONE GROWTH

Derivatization schemes are being investigated to maximize the effectiveness ofseveral commercially available polyurethanes as substrates for bone and tissue growth. Current emphasis is on a derivatization which results in the attachment of a trimethoxyaminosilane group to the PEU substrate. ESCA is being used to characterize the PEU before and after derivatization.